Time-dependent changes in chloride homeostasis are a mechanism of plasticity critical for learning

ABSTRACT
The mechanisms underlying how rewards are learned, and how they translate into behavior have been
a subject of interest to researchers and scientists since Pavlov’s classical conditioning experiments in the
1890s. Recently, Gamma Amino Butyric Acid (GABA) neurons in the Ventral Tegmental Area (VTA) have
emerged as key modulators of reward learning, and potential therapeutic targets for addressing addiction,
depression, and other neuropsychiatric disorders. Previous studies have shown that GABA neurons in the VTA
undergo a form of experience-dependent plasticity that involves the downregulation of the anion transporter,
KCC2. This reduction of KCC2 levels has been found to increase the excitability of GABA neurons by
decreasing the efficacy of GABAA receptor function. In the context of drugs of abuse and aversive stimuli, this
mechanism has been studied in great detail. However, the impact of this mechanism on specific reward-related
pathways and its contribution to naturalistic reward learning remains unknown.
In my thesis work thus far, I have examined whether modifications in KCC2 serve as an innate
mechanism during reward learning that allows the brain to establish enduring associations between
contextual cues and appetitive stimuli. I first characterized the expression of KCC2 throughout the course of
cue-reward associative learning and showed that KCC2 downregulation shifts VTA GABA neurons towards
excitability at critical time points during reward learning. My data also demonstrate that KCC2-mediated
plasticity drives increased synchronized activity between VTA GABA neurons ex vivo. Subsequently, I
demonstrate that VTA GABA neurons exhibit enhanced synchronization in vivo, and it is concurrent with the
same time points when KCC2 downregulation occurs.
This F99/K00 proposal comprises two aims outlined in the following research plan. In Aim 1, I will
examine whether this form of plasticity occurs in vivo, and consequently leads to enhanced synchronized
network activity. To achieve this, I will combine multi-unit silicon recordings with pharmacological and genetic
approaches to manipulate levels of KCC2 and examine neural network dynamics during reward learning. Aim 2
delineates my aspirations to identify and obtain a postdoctoral position. During the K00 phase, I plan to
investigate the molecular, cellular, and neurocircuit-specific mechanisms shaping susceptibility or
resilience to common neuropsychiatric disorders. To this end, my sponsors and I have crafted a thorough
plan for my F99 (predoctoral) and K00 (postdoctoral) phases. The F99/K00 will support my goals for becoming
an independent researcher by facilitating the successful completion of my PhD and bolstering a seamless
transition into a strong postdoctoral position.

Public health relevance
PROJECT NARRATIVE The research proposed under this F99/K00 fellowship will assess the role of KCC2-mediated synaptic plasticity in the VTA during naturalistic reward learning and resulting network-level modifications in this process. This will establish KCC2 modulation as a novel form of synaptic plasticity during reward learning and will demonstrate the potential of KCC2 as a target for intervention to treat neuropsychiatric disorders that are characterized by aberrant reward learning such as obsessive compulsive disorder and schizophrenia, among many others.